Electroporation delivery of pNGVL4aCRTE6E7L2 DNA for treatment of HPV16+ CIN2/3 patients

Project Summary/Abstract: HPV-­associated cancer incidence is significantly elevated in cervical and at
other sites in HIV+ patients. HIV+ patients acquire more frequent multi-­type infections, including many genotypes
infrequently seen in healthy individuals, and not targeted by the current HPV preventive vaccines. We previously
developed a candidate therapeutic and preventive HPV vaccine, pNGVL4a-­CRTE6E7L2 (CRTE6E7L2), which
comprises a DNA vector encoding the heat shock protein calreticulin fused genetically with HPV16 E6 and E7
(that are obligately expressed in HPV malignancies) as well as the L2 capsid protein (a broadly protective
antigen). We showed that fusion with calreticulin (CRT) profoundly enhances the potency of DNA vaccines in
generating HPV antigen-­specific CD8+ T cell mediated immune responses even in CD4-­depleted animals. In
addition, vaccination with the CRTE6E7L2 DNA vaccine induces both L2-­specific neutralizing antibodies and
protection from experimental vaginal challenge. These features make the CRTE6E7L2 DNA vaccine particularly
promising for use in HIV+ patients, a challenging group to treat, and to prevent multiple types of HPV infections.
Although DNA vaccines are relatively safe and well suited for multiple administrations, they generally exhibit
suboptimal immunogenicity when administered by conventional intramuscular needle injection, likely reflect
inefficient host cell transduction. We have previously shown that electroporation is a much more effective DNA
vaccine administration method to generate HPV-­specific CD8+ T cell immune responses as compared to
conventional intramuscular injection or epidermal delivery via gene gun. Thus, the goal of this proposal is to use
the Ichor TriGrid™ Delivery System Electroporation Device, which has been used in multiple clinical trials, for
intramuscular administration of the CRTE6E7L2 DNA vaccine at escalating doses in both HIV– and HIV+ patients
with HPV16-­associated high-­grade cervical intraepithelial neoplasia grades 2 and 3 (CIN2/3), and to examine
the safety, virologic, and disease outcomes. The Specific Aims of this study are to (1) evaluate the safety and
toxicity of CRTE6E7L2 administered via electroporation in HIV– and HIV+ patients with HPV16+ CIN2/3;; (2)
characterize the HPV16 E6/E7-­specific cell-­mediated and humoral immune responses in HIV– and HIV+ patients
with HPV16+ CIN2/3 vaccinated with CRTE6E7L2 via electroporation;; (3) characterize L2-­specific humoral
immune responses in HIV– and HIV+ patients with HPV16-­associated CIN2/3 upon vaccination with
CRTE6E7L2 DNA vaccine via electroporation;; and (4) determine the HPV load and histopathological changes
in the lesion and its microenvironment in HIV– and HIV+ patients with HPV16-­associated CIN2/3 upon treatment
with CRTE6E7L2 DNA vaccine via electroporation. The successful implementation of our proposal will provide
a new methodology for the treatment of HPV-­associated high-­grade squamous intraepithelial lesions in HIV–
and HIV+ patients.

Public health relevance
Project Narrative Human papillomavirus (HPV) type 16 infection causes 50- 60% of all cervical cancers (and ~90% of other HPV- associated anogenital and oropharyngeal cancers), and HIV co- infection increases risk for cancer progression. Here we propose to test a candidate therapeutic and preventive HPV vaccine in HIV– and HIV+ women in whom both HPV16 and the precursor lesion of cervical cancer (CIN2/3) have been detected.